Career Enhancement Program

PROJECT SUMMARY – CAREER ENHANCEMENT PROGRAM (CEP)
Despite recent gains, driven in part by Hillman Cancer Center (HCC) HN SPORE-funded research,
translational research in head and neck squamous cell carcinoma (HNSCC) lags that of many other
malignancies. The HCC HN SPORE is uniquely positioned to build upon its past successes and foster the next
generation of translational scientists studying HNSCC. The Career Enhancement Program (CEP) of the HCC
HN SPORE has been designed to attract, educate and mentor a new, diverse group of scientists committed to
understanding and eradicating HNSCC. HCC and the University of Pittsburgh have committed substantial
funding and infrastructure to this endeavor, with institutional matching to double the number of CEP awards
given annually. Moreover, the HCC HN SPORE is committed to diversity and has recently established
collaborations with Johns Hopkins, Howard University, Emory University and Meharry Medical College to
increase the participation of under-represented minorities in the HCC HN SPORE CEP and, indeed, through
the entirety of the program. In addition, we have appointed Dr. Tullia Bruno, as Co-Director of the CEP. She is
a previous CEP awardee, member of the HCC Women’s Task Force (an initiative launched by Dr. Ferris in late
2017, which addresses gender issues among the female faculty at the Cancer Center) and co-leader of the
Pittsburgh Chapter of the Association for Women in Science, to assist in increasing our number of female
applicants and awardees.
Potential CEP awardees will be new to the study of HNSCC, either because they are junior faculty who are
establishing their careers; established investigators studying other scientific questions who wish to transition to
HNSCC; or clinical investigators well versed in the design and performance of clinical trials who wish to
broaden their translation research experience. The selection process for these awards are rigorous and include
all aspects of HNSCC research. Once awarded, the CEP grantee will meet regularly with a more established
HNSCC investigator with an established record of successful mentorship as well as a mentoring team. They
will be encouraged to participate in courses in clinical and translational research and participate in mock study
sections where their extramural funding applications will be scored by their mentoring team. The goal of this
program is to develop CEP awardees research into larger projects as well as diverse next generation of
HNSCC researchers.

Public health relevance
PROJECT NARRATIVE – CAREER ENHANCEMENT PROGRAM (CEP) The Hillman Cancer Center HN SPORE Career Enhancement Program (CEP) is designed to foster the growth of a new, diverse generation of diverse scientists dedicated to head and neck squamous cell carcinoma (HNSCC) research leading to improvements in the prevention, detection, and therapy of this deadly disease. To accomplish this, we have established collaborations with Johns Hopkins, Howard University, Emory University and Meharry Medical College to increase the representation of underrepresented minorities in the HN SPORE, in addition to several internal initiatives to increase the diversity of the CEP to the benefit of the entire HNSCC research community.